Data & Stats Core

ABSTRACT - DATA MANAGEMENT AND STATISTICS CORE
The Duke/UNC Alzheimer’s Disease Research Center (ADRC) Data Management and Statistics Core provides
essential support to advance understanding of Alzheimer’s disease and Alzheimer’s disease-related dementias
(AD+ADRD). In support of the Duke/UNC ADRC and the broader dementia research community, the Core will
offer two essential functions: integrated data management and statistical/ bioinformatics collaborative expertise.
Building on strong infrastructure at Duke and UNC, the Core proposes the following Specific Aims: 1) Provide
coordinated and integrated data management capabilities across the Duke/UNC ADRC to allow easy access,
tracking, and reporting capabilities for all of the Cores; 2) Provide datasets to the National Alzheimer’s Disease
Coordinating Center (NACC), to other collaborative efforts in Alzheimer’s disease discovery and prevention, and
to AD+ADRD investigators at Duke/UNC; 3) Provide statistical/bioinformatics design and analysis consultation;
4) Develop statistical/bioinformatics methods to meet the needs of the ADRC and AD+ADRD research
community; and 5) Provide educational opportunities and mentoring of investigators, trainees and junior faculty
in collaboration with the Research Education Component on statistical and bioinformatics methodologies for
AD+ADRD research. The Core’s combination of state-of-the-art, integrated data management applications and
comprehensive statistical expertise enable the creation and expansion of high-impact research initiatives at the
ADRC, including innovative multimodal research projects pursuing identification of age-related drivers of AD
through genetics, metabolomics, gerontology, and neuroimaging.